Identification of ACE2 as an early tissue-specific biomarker of GI-ARS using a dual specimen strategy

Project summary/Abstract
Title: Identification of ACE2 as an early tissue-specific biomarker of GI-ARS using a dual specimen strategy
The project aims to develop a novel, dual-specimen biomarker strategy to improve the early detection of
gastrointestinal acute radiation syndrome (GI-ARS), a critical condition that arises from ionizing radiation (IR)
exposure. IR exposure can lead to both hematopoietic (H-ARS) and GI-ARS, but GI-ARS typically manifests
earlier, requiring prompt diagnosis and intervention to improve survival outcomes. Existing GI-ARS biomarkers,
such as serum citrulline, are effective only after the initial 48-hour window post-exposure, limiting their utility in
early clinical interventions. To address this gap, this study will evaluate angiotensin-converting enzyme 2
(ACE2), an enterocyte-specific protein highly responsive to IR, as a promising early biomarker that can be
detected within 1–2 days post-exposure. By combining fecal and serum measurements of ACE2, this project
proposes a sensitive and minimally invasive biomarker strategy for predicting GI-ARS severity with high
accuracy. This study will leverage a dual-specimen approach to provide a more comprehensive measure of GI
injury, capturing both tissue-specific and systemic GI injury responses to IR. Aim 1: will evaluate the temporal
dynamics and dose-dependent changes in fecal and serum ACE2 following IR exposure for early GI-ARS
prediction. Using total-body irradiated (TBI) mouse models, we will monitor ACE2 levels over the critical 1 to
3.5 days post-IR period, hypothesizing that IR will induce a dose-dependent increase in fecal ACE2 (indicating
enterocyte shedding) and a corresponding decrease in serum ACE2 (signaling systemic GI injury). This dual-
specimen strategy is expected to yield a more precise GI-ARS prediction within the first 24–48 hours post-
exposure compared to current markers. Aim 2: will evaluate the predictive value of fecal-to-serum ACE2 ratio-
based biomarkers for early detection and severity of GI-ARS. Using both TBI and total abdominal irradiation
(TAI) models, we will validate the fecal-to-serum ACE2 ratio's ability to reliably indicate GI-ARS severity. We
will further explore whether the fecal ACE2-to-serum citrulline ratio could provide an alternative predictive
metric, especially valuable for mitigating the variability often present in single biomarker models. This study
introduces a dual-specimen ACE2 biomarker strategy that addresses the urgent need for early GI-ARS
detection. By measuring ACE2 in both fecal and serum samples, we offer a minimally invasive approach that
allows for localized (fecal) and systemic (serum) assessment of IR-induced GI injury. The fecal-to-serum ACE2
ratio may improve diagnostic accuracy, surpassing traditional biomarkers such as serum citrulline, particularly
at early time points. This approach is transformative in scenarios of nuclear exposure or mass casualties,
where rapid and reliable GI injury assessment is critical. The study's findings could enable swift clinical
translation, enhancing survival outcomes through timely diagnosis and management of IR-induced GI injuries.
1

Public health relevance
Title: Identification of ACE2 as an early tissue-specific biomarker of GI-ARS using a dual specimen strategy Project Narrative: This project aims to develop a non-invasive biomarker strategy for early detection and prediction of gastrointestinal acute radiation syndrome (GI-ARS) severity by assessing angiotensin-converting enzyme 2 (ACE2) levels in serum and feces. By evaluating compartment-specific changes in ACE2, this dual- specimen approach is expected to provide a more sensitive and accurate metric than current biomarkers, enhancing triage and clinical intervention capabilities following ionizing radiation exposure. 1